Identification and non-invasive measurement of biomarkers of radiation exposure in human skin

Project Summary Abstract:
The skin is a barrier tissue that is impacted by all types of external radiation events and is accessible to non-
invasive testing. Tape stripping of the skin is an effective, well established, and non-invasive method for sampling
both protein and RNA biomarkers in human skin. We have developed a model of studying radiation injury in
human skin by irradiating living human skin grafts carried by immunodeficient NSG mice. Our model recapitulates
both the early inflammatory and late fibrotic changes in skin observed in patients after radiation exposure. We
present pilot spatial profiling and immunostaining data demonstrating that superficial keratinocytes, the cell
population sampled by non-invasive tape stripping, upregulate RNA and protein biomarkers within 24 hours of
radiation exposure and that different biomarkers have the potential to discriminate between 1, 2 and 5 Gy
radiation. In this proposal, we will identify optimal keratinocyte biomarkers of radiation exposure and develop a
point-of-care test to measure them using non-invasive tape stripping. In Aim 1, we will identify, validate and
measure the expression kinetics of keratinocyte biomarkers of radiation exposure (0, 1, 2, 5 Gy) in human skin
grafts carried by NSG mice. Xenium 5000 plex spatial transcriptional profiling will be used to identify candidate
biomarkers (Aim 1A), followed by single cell proteomic measurement of candidate biomarkers using cyclic
immunofluorescence (CyCIF) in both discovery and validation sample cohorts (Aim 1B,C). The kinetics of protein
biomarker expression will then be evaluated via CyCIF on days 1, 2, 3, 5, and 7 after 1, 2, or 5 Gy irradiation
(Aim 1D). In Aim 2, we will use NSG mice grafted with neonatal foreskin and skin obtained from aged patients
(>65 years) to study the utility of identified biomarkers in pediatric and aged individuals. In Aim 3, we will develop
and test a point-of-care test to measure biomarkers using non-invasive tape stripping of the skin. These studies
will generate validated, human cutaneous biomarkers of radiation exposure and a non-invasive test to measure
them that is immediately applicable to the care of humans exposed to radiation.

Public health relevance
Project Narrative: We propose to use immunodeficient mice grafted with living human skin to identify biomarkers of radiation exposure that are expressed by superficial keratinocytes, a cell population that can be studied with noninvasive tape stripping of the skin. We will identify, validate, and study expression kinetics of biomarkers and develop a point-of-care test with the potential to rapidly discriminate exposed from nonexposed and identify individuals likely to require countermeasures and supportive medical care.